DATA COORDINATING CENTER FOR THE 3-D FETAL GROWTH STUDY

The Division of Intramural Population Health Research (DIPHR) is conducting a research study entitled: “Fetal 3D Study (Formerly known as the Fetal Body Composition and Volumes Study) to catalogue and perform 2 Dimensional (2D) and 3 Dimensional (3D) measurement of the obstetrical ultrasound images in the existing bank of singleton and twin gestations collected from the NICHD Fetal Growth Studies. The research study aims to understand the relationship between gravid diseases and longitudinal changes in fetal body composition (subcutaneous fat, lean mass) and visceral measurements (in singletons) over the course of pregnancy, thereby, complimenting available data for the Cohort.